Host-microbiome interactions after lung transplantation and chronic lung allograft dysfunction

PROJECT SUMMARY/ABSTRACT
This project describes a 5-year mentored career development plan with the goal of training the principal
investigator to become an independent physician-scientist who investigates host-microbe interactions in lung
disease. The applicant is a Clinical Instructor in the Pulmonary and Critical Care Division of the Department of
Medicine at the Perelman School of Medicine at the University of Pennsylvania. He is mentored by Ronald
Collman, MD who is a Professor of Medicine and Microbiology and a pioneer in the lung microbiome field and
also an expert in molecular virology. Jason Christie, MD, MSCE is a Professor of Medicine and Epidemiology
who is a molecular epidemiologist with expertise in complications of lung transplantation and the use of
biostatistical methods to model complex lung disease. The research plan uses clinical-translational methodology
and computational biology to gain mechanistic understanding of host-microbiome interactions in the lung after
transplantation and their role in chronic lung allograft dysfunction (CLAD)—the most common cause of graft
failure and death after one-year post-transplant. This proposal responds directly to NHLBI’s Strategic Vision
objective to understand the influence of the microbiome on lung health.
With the support of this K23 award, Dr. McGinniss will in Aim 1 analyze the microbiome of bronchoalveolar
lavage fluid (BAL) from a longitudinal cohort study of lung transplant patients at risk of CLAD. He will use
advanced biostatistical approaches to understand the relation of early lung microbiome dysbiosis—changes in
the composition, relative abundance, or function of microbes—in the first year after transplant and later CLAD.
In Aim 2 he will create a CLAD case-control study of 24 cases and 24 matched controls. He will enroll the final
12 cases and 12 controls. He will use this case-control study to perform a multi-omic analysis of the microbiome
and host responses to understand mechanisms of CLAD. In Aim 3, he will use unbiased metabolomics to
discover novel biomarkers and to interrogate metabolic dysregulation in CLAD. He will also assess the role the
metabolome has in mediating pathological host-microbe interactions. In addition, he will do targeted analysis of
the metabolome and inflammatory markers in longitudinal cohort study to assess if they are aberrant before the
diagnosis of CLAD.
Dr. McGinniss has outlined a rigorous training plan of coursework, skills acquisition (with a focus on clinical-
translational methods, computational biology, and advanced metagenomics), and career development. He has
assembled a distinguished, multidisciplinary mentorship team to realize this vision. Penn provides an exceptional
intellectual and collaborative environment for this proposal with considerable resources in the PennCHOP
Microbiome Program and the Institute of Translational Medicine Therapeutics (ITMAT) that will be leveraged in
this award. Dr. McGinniss is well-positioned to successfully compete the aims and training plan so that he will
be a competitive applicant for an R01 award further exploring host-microbe interactions in chronic lung disease.

Public health relevance
PROJECT NARRATIVE Lung transplantation is the only therapy for patients with end-stage lung disease, however survival is only ~50% by 5 years and most of the late morbidity and mortality is driven by chronic lung allograft dysfunction (CLAD). The lung microbiome, that is the collection of microbes that can be identified by sequencing, has been shown to regulate immune tone and has been implicated in multiple chronic lung diseases. In this application, the candidate proposes a detailed examination of the lung microbiome after lung transplantation and seeks to gain an understanding of the role it may play in CLAD with the hope that this knowledge can be used to improve the care of patients after lung transplantation.